Use of Focused ultrasound stimulated blood brain barrier opening for CNS HIV/SIV reservoir reduction

Abstract
The advent of combination anti-retroviral therapy (cART) has prolonged the lifespans of people living with HIV.
However, upon cessation of ART treatment the virus quickly rebounds. One of the likely causes for this rebound
is the rapid seeding and establishment of viral reservoirs in multiple tissue compartments including the central
nervous system (CNS). The CNS is a sanctuary site for HIV due to the presence of barriers such as the blood
brain barrier (BBB) and choroid plexus. These structures significantly limit the CNS delivery of ART drugs which
prevents control of viral replication and the associated negative effects on cognition. Therefore, novel strategies
need to be developed for both treatment and viral reservoir clearance in the brain. We recently optimized a novel
technique called focused ultrasound induced blood brain barrier opening (FUSS-BBBO) to overcome BBB
permeability constraints. FUS-BBBO has been safely and successfully used to deliver anticancer chemotherapy
drugs directly into brain tumors in human patients and target large brain regions in rodents and nonhuman
primates for gene delivery. FUS-BBBO uses low-intensity ultrasound with systemically administered
microbubbles, which oscillate in blood vessels at the ultrasound focus, resulting in safe, localized, temporary (6-
24 h), and reversible opening of the BBB. FUS-BBBO has been successfully used to deliver proteins, small
molecules, and viral vectors without inflicting detectable tissue damage in both rodents and nonhuman primates.
Therefore, in the present study, we will use FUS-BBBO to deliver long-acting cART (Cabotegravir and Islatravir)
drugs in conjunction with an anti-inflammatory delta-9-tetrahydrocannabinol treatment to two specific areas of
the brain (basal ganglia and hippocampus) known to be targeted by HIV/SIV for better control of viral replication
and persistence. In addition, we will use Adeno-Associated vector particles to deliver a gene therapeutic blocking
SIV infection (anti-SIV glycosylphosphatidylinositol-anchored single chain variable fragments (scFvs) to brain
resident macrophages and microglia for durable suppression of viral replication in the brain following cART
interruption. These new technologies will be tested in the SIV-infected rhesus macaque model that shows
consistent CNS infection, and neuroinflammation under suppressive cART. While both Cabotegravir and
Islatravir have been independently demonstrated to reduce plasma viremia in the human and rhesus macaques,
our studies will for the first time directly test the efficacy of these drugs administered using subdermal nanofluidic
implants on HIV/SIV replication in brain resident perivascular macrophages and microglia. The proposed studies
will help establish the FUS-BBBO method to increase cART drug delivery to the brain for reduction of neuro-
HIV/SIV infection and its adverse effects on brain function. Finally, these studies will also help evaluate the safety
and efficacy of FUS-BBBO delivery of long-acting cARTs and novel AAV-delivered anti-HIV/SIV inhibitors to the
brain.

Public health relevance
Narrative The reduced permeability of the blood brain barrier (BBB) to anti-retroviral drugs poses a major impediment to the effective treatment and reduction of HIV/SIV persistence in the brain leading to a greater incidence of HIV associated neurocognitive disorders in people living with HIV. In the proposed study, we will utilize a novel technique called focused ultrasound (FUS) to reversibly open the BBB to allow higher levels of combination anti- retroviral therapy (cART) drugs to permeate into deeper areas of the brain for better suppression of viral replication and reduction of the size of the brain HIV/SIV reservoir pool. Knowledge from the proposed studies will help establish the FUS-BBBO method to increase cART drug availability in the brain for reduction of neuro- HIV/SIV infection and its adverse effects on cognition.